Resolving functional aggregates: A new perspective on innate immune control

Pattern Recognition Receptors (PRRs) in the innate immune system form the first line of defense against a
broad range of pathogens. PRRs and their downstream signaling molecules often form aggregate-like
macromolecular assemblies and that they utilize such assemblies for their immunological functions. These
findings have transformed our understanding of how the innate immune system detects microbial infection and
how it activates the anti-microbial immune response. However, how these “functional aggregates” are
resolved upon their assembly to ensure transient activation of the potentially harmful inflammatory
signal is not known. How do these functional aggregates interact with the cellular protein quality control
(PQC) system, charged with resolving misfolded protein aggregates (e.g. amyloids)? Is there a commonality or
rather a divergence in cellular response to functional vs. dysfunctional misfolded aggregates? The current
application aims to address these questions by exploring the connections between innate immunity and PQC.
This is uncharted territory, with only few relevant studies that address such questions. Our strategy is to utilize
multidisciplinary approaches, from systematic functional screens to biochemical reconstitution and to structural
dissection. The combination of these approaches is sure to generate deep mechanistic understanding of how
functional aggregates in innate immunity are resolved. It will also provide a new paradigm for how the innate
immune system is regulated and how it can be further controlled for therapeutic gains. Furthermore,
considering the emerging view that many proteins form aggregates-like assemblies or granules as part of
normal physiology (e.g. cytosolic RNA granules and nuclear speckles), our findings and strategies have
implications far beyond the innate immune system.
The current application represents a new direction in my research. Unlike our previous and current work,
which has largely focused on the mechanisms of how microbial infection activates innate immune response,
this application focuses on the mechanisms of how cells turn off the immune signaling once activated. In
particular, I propose to explore the previously unappreciated interface between innate immunity and cellular
PQC, seeking new unifying principles governing both innate immune signaling complexes and misfolded
dysfunctional aggregates. Underlying this application is my general scientific approach of identifying novel
connections between disciplines and pushing the existing boundaries of the fields. While this proposal deals
with highly risky and challenging problems, as one of the pioneering laboratories for the discovery of functional
aggregates in innate immunity, I believe that we are uniquely positioned to open this new area of research.

Public health relevance
Innate immune system is a first line of defense against a broad range of pathogens, but dysregulated innate immune functions can also cause a spectrum of inflammatory disorders. The goal of the current proposal is to understand the molecular mechanisms of how the innate immune system is regulated, in particular how the macromolecular signaling complexes are resolved upon activation. The proposed research would deepen our mechanistic understanding of the innate immune system and guide us in developing therapeutic strategies to control its activity.